Support of Yerkes National Primate Research Center

This application seeks five years of continued support for the Base Grant (P51 RR00165) for the Yerkes National Primate Research Center of Emory University. The operation ofthe Yerkes NPRC is guided by the NCRR Program Guidelines for NPRCs (Sixth Edition). The YNPRC, as documented herein, has recorded substantial progress in the present reporting period, and also here presents comprehensive plans for the next five years (5/1/2011 - 4/30/2016). The objectives in this application are aligned to our mission of providing the comprehensive research infrastructure required to conduct a research program largely funded by extramural grants and other funding mechanisms, chiefly from NIH. Continued P51 funding is requested for all or part ofthe following components to support the Center's scientific mission: Administration, including scientific leadership and overall management, business services, information technology, human resources, and public affairs;Facilities Management;Research Resources, including veterinary medicine, animal care, colony management, animal records, and behavioral management;as vi/ell as service pathology, environmental health and safety, and research services to provide comprehensive support to outside investigators;and three Science Service Cores: Biomarkers, Imaging, and Virology. Support is also sought for four scientific divisions: Microbiology and Immunology, Neuropharmacology and Neurologic Diseases, Developmental and Cognitive Neuroscience and Behavioral Neuroscience and Psychiatric Disorders. Additionally, support is requested for five Pilot Research Projects to allow Center investigators to collect preliminary data and develop improved methodologies in areas likely to lead to subsequent external support. Support is also sought for two resource enhancement grants. Finally, support is requested under Improvement and Modernization to enhance elements ofthe infrastructure. The Yerkes NPRCs central goal is to support a research program focused on scientific problems relevant to human health, and to provide the resource infrastructure and expertise in appropriate scientific and veterinary specialties to support such a program. Additional Yerkes goals are to enhance the Center's ability to serve as a resource to core investigators and to scientists nationally and internationally, as well as to provide educational and training opportunities.